Post-translational regulation of hepatitis B virus large envelope protein

Project Summary/Abstract
The large (L) envelope protein of hepatitis B virus (HBV) is essential for virion production
and infectivity, and its high intracellular level can cause liver cancer. It has extra preS1 + preS2
domains than small (S) envelope protein. Majority of the S protein is secreted as noninfectious
subviral particles (SVPs), which have been implicated in the induction of immune tolerance for
establishment of chronic HBV infection. L protein is not secreted when expressed alone. It interacts
with core particle to initiate virion morphogenesis, and recruits the S protein for virion secretion. In
doing so it also suppresses SVP secretion according to L/S protein ratio. L protein is also essential
for initiation of HBV infection by interacting with the high-affinity receptor. Despite its critical
importance in HBV biology and pathogenesis, little is known about regulation of its intracellular level
at the post-translational step. We previously found that preventing S protein expression by mutating
the initiating ATG into GCG abolished M protein, suggesting its reliance on S protein for stability.
The intracellular level of L protein was also markedly reduced despite blocked secretion. Very
recently, we discovered this particular mutant could produce a shortened and non-secreted S
protein through translation initiation from a downstream ATG. Further mutating that ATG into GCG
diminished intracellular L protein to extremely low level. Nevertheless, mutating the first and second
in-frame ATG codons in the S gene into GCG introduces amino acid substitutions in the S domain
of L protein. To verify that reduced L protein level is attributed to lost S protein expression rather
than mutations in L protein, in Aim 1 we will test the impact of mutating the S gene ATG codon into
other codons such as ATA, AAG, and TTG. The preS1 region harbors the promoter for 2.1-kb RNA
for M/S proteins, and we recently found many naturally occurring in-frame preS1 deletions
abolished S protein expression. Whether lost S protein expression at the transcriptional level also
diminishes intracellular level of shortened L protein will be determined. Aim 2 will establish the role
of core protein in sustaining L protein level and check for its synergy with S protein. Our pilot study
suggested that core protein expression was required to sustain both intracellular and extracellular
levels of L protein. In Aim 3, we will verify whether much reduced intracellular level of L protein is
attributed to accelerated degradation, and examine if providing S or core protein in trans can rescue
the L protein level. We hypothesize that during HBV virion morphogenesis, L protein is stabilized by
its molecular interaction with core particles or with S protein. The proposed studies will reveal a
novel mechanism to control L protein level at the post-translational level, which should have
therapeutic implications.

Public health relevance
Project Narrative Hepatitis B virus large envelope protein is essential for virion production and infectivity, and its high intracellular level can cause liver cancer. Based on encouraging preliminary study, we will verify whether its sustained intracellular level requires co-expression of small envelope protein or core protein, and whether it is rapidly degraded if expressed alone. The proposed studies may identify a novel mechanism whereby intracellular level of large envelope protein is controlled at a post- translational level, which should have important biological, clinical, and therapeutic implications.